BLR&D Research Career Scientist Award Application

Numerous cross-sectional and longitudinal studies have established that circulating levels of testosterone
decline with age in men. Likewise, human aging also results in a gradual decline in ovarian steroid production,
a dramatic decline in adrenal androgens (DHEA, DHEAS), and alterations in cortisol and aldosterone
production and secretion. Similar to humans, aging in experimental rodents is also associated with profound
changes in the synthesis and secretion of steroid hormones, particularly testosterone. For the past 33 years or
so (with almost continuous support through Merit Review funding), my laboratory has been actively involved in
delineating cellular and molecular mechanisms involved in the age-related decline in steroid hormone
biosynthesis and secretion, with a particular emphasis on testosterone. Our work during the past several years
has established a causal link between increased reactive oxygen species formation/excessive oxidative stress
and oxidative damage to the cellular machinery involved in cholesterol transport to mitochondria resulting in
attenuated cholesterol transport with consequent impairment of steroidogenesis during aging. Currently, we
are investigating the impact of aging-induced excessive oxidative damage to cytosolic and mitochondrial
superoxide dismutase-peroxiredoxin (SOD-PRDX) antioxidant axes on the functional expression of crucial
proteins involved in cholesterol transport (SNAREs) to and within the mitochondria (StAR) for the production of
steroid precursor, pregnenolone. Over the years, a second major research effort of my laboratory has been
and continues to be to understand how cholesterol from lipoproteins, particularly, high-density lipoprotein
(HDL), is transported, processed intracellularly, and metabolized by steroidogenic tissues and cells. We are
also studying how this process affects steroid hormone synthesis, reverse cholesterol transport (RCT), and
atherosclerosis. Our work on HDL metabolism (funded by NIH since 1984), have led to the demonstration that
the cellular delivery of HDL-cholesteryl esters (CE) into steroidogenic cells does not involve the endocytic
pathway as typified by the LDL (B/E) receptor pathway. Rather, CE is taken into the cell via a `selective'
pathway in a process that did not require the internalization of the entire lipoprotein particle. This selective
pathway has been extensively characterized by us and it is especially important in liver and steroidogenic
tissues where it delivers CE in bulk for product formation (steroid and bile acids) and biliary cholesterol
secretion as a part of RCT. Scavenger receptor, class B type 1 (SR-B1) is an HDL receptor that mediates
selective delivery of HDL-CEs in steroidogenic and hepatic tissues and is also implicated in the
pathophysiology of RCT and atherosclerosis. At present, we are investigating the transcriptional and
posttranscriptional regulation of SR-B1 and its relevance to steroidogenesis, RCT, and atherosclerosis.
Currently, we are working on two additional projects. One project is focused on defining the lipid lowering and
anti-hyperglycemic actions of creosote bush-derived nordihydroguaiaretic acid (NDGA). Previous work from
our laboratory has shown that NDGA, has profound effects on the core components of the metabolic syndrome
(MetS) including lowering of blood glucose, free fatty acids, and triglyceride (TG) levels in several models of
dyslipidemia, as well as improving body weight (obesity), insulin resistance, diabetes, hypertension, and
ameliorating hepatic steatosis. The current focus of this project is to elucidate the molecular mechanism by
which NDGA exerts its hypolipidemic actions in the major insulin-sensitive tissues, liver, skeletal muscle, and
adipose tissue, and improves dyslipidemia, insulin sensitivity and hepatic steatosis. In another project, efficacy
of several dual function apoA-I mimetic peptides (Artery Therapeutics, Inc.) engineered to mimic anti-
atherosclerotic and anti-diabetic functionalities, is being evaluated using several mouse models
atherosclerosis, diabetes, and obesity.

Public health relevance
The goal of our aging project is to provide mechanistic information by which aging-induced excessive oxidative stress contributes to the age-related decline in steroid synthesis in experimental rodent models. Successful completion of the proposed studies may identify novel target(s) that can be exploited in the management of clinical conditions such as hypogonadism, sexual dysfunction, dyslipidemia, and others in older Veterans and the general aging population. The studies under Project 2 should provide new insights into the mechanism by which SR-BI/selective HDL-CE pathway helps to eliminate excess cholesterol by the liver and steroidogenic cells. Such understanding will aid development of new drugs to treat heart and other diseases related to dyslipidemia and/or production of bile acids and steroids in both the general and Veterans population. Our work on NDGA and dual function mimetic peptides should enhance our understanding about the pathogenesis of dyslipidemia, atherosclerosis, metabolic syndrome, diabetes, and nonalcoholic fatty liver disease.